Quantitative control of phosphorylation and mechanistic links to immune cell decisions

ABSTRACT
Cells integrate distinct stimuli through biochemical signaling pathways to induce the appropriate transcriptional
programs. In these signaling-to-transcription networks, the rapid addition and removal of post-translational
modifications impact the activity and specificity of transcription factors (TFs) to inform resultant cellular function.
Understanding how extracellular cues are linked to gene expression is a fundamental challenge in
biology. Existing signaling-to-transcription efforts are often constrained in scope, describing signaling events in
detail with little transcriptional insights, or focusing on a few static signaling features while addressing more
comprehensive genomic questions. My laboratory is addressing this problem in the context of signal transducers
and activators of transcription (STATs), a family of TFs that integrate complex cytokine stimuli to inform a range
of pro- to anti-inflammatory immune programs. We propose both data-driven and mechanistic modeling
approaches to integrate TF dynamics, global phosphorylation, and transcriptomic data to 1) explore signaling
mechanisms that shape stimulus-specific STAT phosphorylation dynamics and functions dependent on these
dynamics, and 2) systematically identify phosphorylation events and STAT-cooperating TFs that predict specific
gene sets. These efforts to link dynamic signaling to gene expression profiles are a step towards identifying and
manipulating the biochemical events required for healthy versus pathology-associated gene expression.

Public health relevance
PROJECT NARRATIVE The microenvironment shapes cellular function and this process involves transmitting signals from extracellular cues to a specific set of response genes. Our goal is to understand how the factors that transmit signals and direct gene expression can initiate diverse, yet context-specific gene programs, thus yielding insights into dysregulated gene expression and disease susceptibility. This work is highly relevant to NIGMS’s mission of seeking fundamental understanding of biological processes to lay foundations for novel therapeutic strategies.